Decision-making abilities in Alzheimer's disease and related dementias: From clinical standards to decision neuroscience

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease and related dementias are marked by early and significant impairments in decision-
making, often with disastrous consequences for patients and their families. While recent research in decision
neuroscience and neuroeconomics holds great promise for elucidating neural mechanisms underlying these
impairments (and ultimately, for achieving a deeper understanding that can yield strategies for improving
patients’ decisions), in many cases it remains unclear how neuroscientific findings can be applied to the
decision-making errors that patients exhibit in real life. This translational gap between cutting-edge research
and clinical practice will be addressed in the proposed work by linking current decision neuroscience to
clinical standards routinely applied in the assessment of patients’ decision-making abilities. On a widely-
accepted standard, impaired decisions in dementia and other cognitive disorders can result from failures to:
(1) understand relevant features of a decision, (2) appreciate how this relates to one’s own situation, (3)
rationally manipulate information to arrive at a decision, or (4) consistently evidence a choice. These criteria
reflect clinicians’ expertise with patients’ impairments and embody mechanistic assumptions about how
people make decisions and how decision-making is compromised in disease—assumptions that can now be
investigated empirically using tools of decision neuroscience. The proposed research is organized around
three specific aims that represent links between current neuroscience and accepted clinical standards:
1 (Appreciation): Investigate metacognitive impairments in different dementia syndromes in value-based
choice. 2 (Reasoning): Elucidate mechanisms for applying relevant information to decision-making, which are
disrupted in Alzheimer’s disease. 3 (Choice): Assess inconsistency in revealed preferences in different
dementia syndromes. In this work we will draw from well-characterized cohorts of patients with Alzheimer’s
disease, patients with frontotemporal dementia, and healthy older controls, all with linked clinical and
neuroimaging data. Multiple cohorts will allow for specific associations between syndromes or targeted brain
structures and abnormal decisions; otherwise, generic effects of illness or diminished cognition often cannot
be excluded. Aims 1 & 3 will be pursued using computer-based behavioral testing with decision-making
tasks, while Aim 2 will be pursued using task-based fMRI during a decision-making task. The innovative
approach will enhance external validity (by linking results to the work of clinical experts about the decisional
impairments that patients exhibit in daily life) and rigor (using comparisons across diseases to assure that
findings reflect specific neural effects rather than other confounds). The proposed work is therefore poised to
make a significant contribution by linking decision neuroscience with widely-accepted clinical standards to
advance our understanding of mechanisms of clinical decision-making impairments, ultimately resulting in
improved assessment tools and in targets for future interventions to prevent serious harms to patients.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH SIGNIFICANCE The proposed research is relevant to public health because decision-making impairments often have devastating consequences for patients with Alzheimer’s disease and related dementias. We propose three lines of inquiry that each bridge gaps between contemporary decision neuroscience and clinical standards routinely applied in the assessment of dementia and other cognitive disorders. This translational effort represents a necessary step towards realizing the potential of decision neuroscience to identify mechanisms of impairment in illness, mitigate risks to patients, and enhance patients’ ability to make sound decisions.